Virtual Resection to Treat Epilepsy

More than 1/3 of the world’s 65 million people with epilepsy (~3.3 million in the U.S.) have seizures that cannot be controlled by medications. Surgery and implanted devices are options for many, but their success depends upon manually mapping epileptic networks, which is only possible for some patients, and poorly standardized. When surgical targets are identified, there is currently no rigorous way to select the best surgical approach. The overall aim of this proposal is to develop rigorous, standardized, quantitative methods to: (1) map epileptic networks from imaging and Stereo EEG (SEEG), (2) pick the best region for resection, ablation or neuromodulation for individual patients from their data and clinical hypotheses, and (3) to determine when focal intervention is unlikely to succeed. These methods would have tremendous positive impact on clinical care. Over the first four years of this grant we have made substantial progress towards these goals. Our deliverables include: (1) robust measures derived from intracranial EEG (IEEG) that predict outcome from epilepsy surgery; (2) personalized methods that localize epileptic networks and predict the impact of different interventions on seizure control; (3) tools that predict the path of seizure spread from combined MRI and iEEG; and (4) a track record of openly sharing our methods, data, results and code on our platform http: //ieeg.org. In the next phase, we propose innovative solutions to 3 fundamental challenges in epilepsy surgery required to translate our work into practice: (1) Guiding SEEG: We must adapt our methods to the sparser sampling and different philosophy of stereo EEG, which maps a network of connected brain regions and tests clinical hypotheses about where seizures initiate and propagate; (2) Assessing sampling bias and missing information: We will develop methods to determine if electrodes sample all key regions of the epileptic network, to ensure we do not falsely localize due to missing information; (3) Validating in a larger population across centers: In parallel to refining the above methods, we will validate and optimize our analyses in a large number of patients to ready this work for a prospective clinical trial. In a novel model, we have engaged a group of major surgical epilepsy centers to openly collaborate, standardize methods, aggregate data, and share all algorithms, computer code, data and results on http: //ieeg.org. Our central hypothesis is that standardized, quantitative methods to guide epilepsy surgery can improve patient outcomes, lower morbidity, reduce cost and enable uniform, higher quality care across centers. This work is significant because it merges state of the art network neuroscience, engineering, neurology and neurosurgery to make practical tools to improve and standardize patient care. This project leverages a thriving collaboration between experts in neurology, computational neuroscience, neurosurgery, neuroimaging and bioengineering at the University of Pennsylvania that has generated 58 publications related to this proposal. We now extend this collaboration to academic epilepsy centers across the United States and worldwide.

Public health relevance
Project Narrative The proposed research is relevant to public health because developing new quantitative methods to target and test epilepsy surgery in computer models before doing these procedures in the operating room will improve patient outcomes and reduce surgery side effects and costs. In this research we are also working with 15 major epilepsy centers to standardize treatment. For these reasons the proposal is relevant to part of the NIH’s mission to foster fundamental, creative discoveries and innovative research strategies that will ultimately protect and improve human health for the United States’ 3.3 million people with epilepsy.